VALIDATION OF SPECTRAL ANALYSIS AS A NONINVASIVE TOOL TO ASSESS AER

To validate changes in the spectral content (and mean values) of cardiopulmonary variables which consistently correlate with changes in sympathovagal balance of autonomic control of cardiovascular regulation.